Pathogenesis of Early- Versus Late-Stage Alcohol-Mediated White Matter Degeneration

Chronic heavy or binge alcohol consumption damages the structural and functional integrity of the brain.
Ethanol’s neurotoxic and degenerative effects target white matter (WM) across the lifespan, resulting in loss of
myelin, impaired myelin maintenance, and degeneration of axons. Since WM integrity is critical to many CNS
functions, better understanding of how ethanol exerts its adverse effects on WM is needed to prevent or
remediate the associated neurobehavioral and cognitive deficits. Oligodendrocyte dysfunction is at the core of
WM degeneration since oligodendroglia are responsible for synthesizing and maintaining myelin. Myelin is
needed to support and protect axons and ensure efficient neuronal conductivity. We hypothesize that alcohol-
related brain degeneration (ARBD) involving WM could be divided into: 1) an early, reversible stage that is
mainly associated with myelin loss and mediated by oxidative stress, inflammation, and neurotoxic ceramide
accumulation via myelin breakdown and dysregulation of lipid metabolism; and 2) a later stage marked by
impaired insulin/IGF-1 signaling through PI3K-Akt-mTOR-mTORC. Consequences of the latter include loss of
mature oligodendrocytes and compact myelin, impaired maturation of oligodendroglia, axonal damage, and
further progressive dysregulated sphingolipid metabolism with ceramide accumulation and sulfatide depletion.
We anticipate that abstinence will be sufficient to remediate early stages of WM ARBD, whereas active
interventions, such as insulin sensitizer treatments, will be required to reverse WM damage sustained by long
periods of heavy alcohol exposure. However, both early and late stages of ARBD will likely respond to ceramide
inhibitors such as myriocin. Aim 1 will characterize the structural, biochemical and molecular pathologies of
early-stage WM ARBD in an established rat model of chronic ethanol exposure. Aim 2 will utilize a rat model
and human postmortem brains to assess the roles of impaired insulin/IGF-1 signaling through PI3K-Akt-mTOR
and mTORC1 versus mTORC2 as drivers of oligodendrocyte dysfunction and altered sphingolipid metabolism
in the later stages of WM ARBD. Aim 3 will evaluate the effectiveness of abstinence, ceramide inhibitor, and
insulin sensitizer treatments in remediating oligodendrocyte dysfunction and associated alterations in myelin
sphingolipid composition in early versus late stages of WM ARBD. In addition, a novel sub-aim will determine
the degree to which ethanol-induced CNS WM myelin sphingolipid abnormalities and their responses to
treatment can be detected in peripheral blood mononuclear cells (PBMCs). Our underlying hypotheses are
addressed through the use of quantitative immunohistochemistry, electron microscopy, multiplex ELISAs,
mRNA studies, and Matrix-assisted laser desorption/ionization-imaging mass spectrometry. The research plan
is novel, mechanistic, robust, transparent, and inclusive of both sexes, human validation studies, prospects for
stratifying treatment according to ARBD stage, and approaches for potentially monitoring ARBD-associated
WM biochemical pathology and responses to treatment with non-invasive PBMC assays.

Public health relevance
The goals of this research are to characterize short-term versus long-term progressive biochemical and molecular indices of ethanol-induced cerebral white matter (WM) degeneration in relation to oligodendrocyte dysfunction. We propose that early abstinence-reversible adverse effects of ethanol on WM myelin are mediated by inflammatory and stress-induced increases in ceramide whereas more sustained chronic degeneration is due to impairments in insulin/IGF signaling through PI3K-Akt-mTOR with attendant compromises to oligodendroglial maturation, leading to pathogenic declines in sulfatide and increases in ceramide. We plan to assess therapeutic responses to abstinence, insulin sensitizers and inhibitors of ceramide biosynthesis in relation to stage of WM degeneration and cognitive impairment, and explore the degree to which co-existent PBMC membrane lipid abnormalities correlate with those present in WM as a potential non-invasive means of monitoring CNS WM degeneration and treatment responses.